A Phase I Combination Study of Durvalumab and Vicinium in BCG refractory NMIBC

We have drafted a full protocol that has been approved by the NIH CCR and we have received assurances from two separate companies who will be providing drugs for the trial through two separate cooperative agreements (CRADA). It has also cleared the IRB with minimal recommendations and so once approved, we will be set for enrollment. We have several scientific correlative studies planned as described above in addition to our main outcome of safety. We have also coordinated the study in collaboration with Dr. Apolo from Medical Oncology.